Research Leadership Development Program for Diverse Early Career Scientists

PROJECT SUMMARY
Leadership and Educational Advancement Program for Diverse Scholars
This proposed project is an evidence-informed mentoring and leadership development program
for early career social and behavioral scientists from underrepresented racial and ethnic
populations who show promise in research related to the NIDDK mission but who have not yet
received R01 funding and have not ascended to a leadership position in their respective disciplines
or professional associations. Three cohorts of 10 postdoctoral scholars from underrepresented
populations will be recruited to participate over the course of five years. Each mentee will take
part in a two-year mentorship program and will be matched with volunteer mentors who are
leading researcher in diabetes and other endocrine and metabolic diseases, have expertise in the
trainee’s area of interest, and who have a track record of receiving federal funding. Training
mechanisms will include: 1) online group training sessions focused on critical topics associated
developing a successful research proposal in diabetes, endocrine or other metabolic diseases; 2)
1:1 mentoring from volunteer mentors; 3) a hybrid virtual and in-person leadership development
course; 4) a leadership shadowing program; and 5) executive coaching. The program will help
trainees to 1) conceptualize, draft, and submit a high-quality research application to an
appropriate federal funding mechanism (particularly NIDDK and other NIH agencies) or national
foundation, and 2) obtain the relevant leadership skills necessary to become competitive for
leadership positions in academic careers of interest to NIDDK. The program also aims to support
opportunities to increase diverse scientific leadership at the American Psychological Association
through the leadership shadowing program.

Public health relevance
PROJECT NARRATIVE The Leadership and Educational Advancement Program (LEAP) for Diverse Scholars is an evidence- informed mentoring and leadership development program for early career social and behavioral scientists from underrepresented racial and ethnic populations who show promise in research related to the National Institutes on Diabetes Digestive and Kidney Disorders (NIDDK) mission but who have not yet received R01 funding and have not ascended to a leadership position in their respective disciplines or professional associations. A longer-term goal of the project is to help diversify the scientific workforce in order to improve research innovation and opportunities for diverse research teams to collaborate on research in the NIDDK-mission areas and enhance health, lengthen life, and reduce illness and disability particularly in underserved populations.